The Oro-Respiratory-Gut Virome Axis Over Space and Time

Overall - Abstract
The human virome is vast, differs among human individuals, and changes over the human lifespan. While the
virome influences human health in diverse ways, true understanding of its impact is limited by incomplete
characterization of the human virome composition. The goal of the Penn Virome Characterization Center (VCC),
titled “The Oro-Respiratory-Gut Virome Axis Over Space and Time”, is to define the human virome and its
dynamics in priority body sites in generally healthy individuals without acute illnesses, reflecting typical US
populations across diverse lifespan and community participants. Our program will provide key insights into
virome composition, richness and complexity, and produce extensive data and methodologies for future studies
of disease associations. We will focus on key body sites identified by the NIH Human Virome Program as priority
targets, including Oral/Dental, Gut (fecal), Respiratory Tract (upper and lower) and Blood. Our collaborative
team has published extensively on the microbiome and virome, and in the course of these studies assembled
unique cohorts with biobanked specimen repositories suitable for rapid initiation of the Penn VCC program. Most
of our sampling is from an urban setting in the mid-Atlantic region, so that African Americans are particularly well
represented. To achieve our goals, the Penn VCC will:
(a) Take advantage of rich in hand biobanks of human samples for rapid efficient analysis, and enroll and
phenotype new subjects to obtain longitudinal oro-respiratory-gut-blood specimens, from existing cohorts of
healthy children, adolescents, adults and elderly individuals; (b) Comprehensively describe and quantify virome
populations from distinct oro-respiratory-gut-blood sites, including viruses of humans, bacteria, and human
eukaryotic commensals, and implement methods for molecular identification of host cells for novel viruses and
characterization of viral DNA modification; (e) Define the commonalities and differences of virome communities
across oro-respiratory-gut biogeography and blood over time within individuals and between age groups; (f)
Protect participants, investigators, and NIH by ensuring adherence to ethical norms and regulatory requirements,
while conducting rigorous legal and qualitative research that addresses unanswered questions raised by human
virome research that will inform future policy and research practice via our Ethical, Legal, and Social Implications
Core; (g) Ensure harmonization and integration with other VCCs of the Human Virome Program, and establish
open sharing of data to maximize research value; (h) Support collaborative research among HVP investigators
using specimens, data, and novel insights generated through the VCC; and (i) Ensure representation of
traditionally under-studied populations as research participants, and enhance diversity and inclusion within the
virology, microbiome and computational biology research communities.

Public health relevance
Project Narrative Penn Virome Characterization Center (VCC): The Oro-Respiratory-Gut Virome Axis Over Space and Time The human body is inhabited in and on many body sites by a diverse population of viruses (the virome) that grow both in human cells and in cells of other microorganisms that live in and on the human body (the microbiome). How the virome affects human health and disease is not well understood, however, in large part because the composition of the human virome has not been completely studied. The Penn VCC will analyze the human virome in several body sites of healthy children and adults from diverse communities in order to better understand the nature of the human virome.